Negative Regulation of Osteoclastogenesis

Many pathological conditions associated with excessive bone loss are characterized by increased
generation of osteoclasts, myeloid lineage cells that resorb bone. The long term goals of this project are to
elucidate molecular pathways and mechanisms that regulate myeloid cell function and osteoclastogenesis
under pathological inflammatory conditions, with the associated goal of using this information to develop
new therapeutic approaches to suppress pathological bone resorption.
Inflammation is an important driver of pathological bone loss in diseases such as rheumatoid arthritis
and infections. Pathological inflammation-associated bone loss is resistant to standard anti-resorptive
therapies; thus, development of new treatments represents an important unmet medical need.
In the previous cycle of this application, we defined epigenetic and metabolic mechanisms by which
inflammatory cytokines, interferon- (IFN-) and hypoxia regulate osteoclastogenesis. We tested the
pathophysiological importance of these mechanisms in models of inflammatory bone loss including arthritis,
implant loosening, supracalvareal osteolysis, and orthopedic periprosthetic joint infection (PJI). PJI is a
devastating complication of joint replacement surgery that is resistant to treatment and a major cause of
morbidity, and even mortality, in orthopedics. One aspect of PJI is biofilm-associated infection at the bone-
implant interface which results in boss loss and implant loosening.
Using a clinically relevant tibial implant model of persistent biofilm-associated Staphylococcus
aureus PJI, we observed bone loss and failure of osseointegration. This was associated with sustained
inflammation at sites of infection, but adaptive immune T cells were suppressed. Advancing the literature
demonstrating myeloid-derived suppressor cells (MDSCs) that suppress T cells in S. aureus infections, we
newly identified expression of inhibitory genes in the setting of a strong IFN- signature, an osteoclastogenic
program selectively at the bone-implant interface, and altered myelopoiesis in the distal bone marrow.
Inhibitory gene expression was markedly higher in tissue adjacent to the implant and biofilm, relative to soft
tissues infected with planktonic phase S. aureus. Based on these results, our overarching hypothesis is that
S. aureus PJI infection induces sustained inflammation that drives osteoclastogenesis, but concomitantly
induces feedback inhibitory mechanisms that suppress adaptive immunity and attenuate clearance of
infection, resulting in substantial morbidity.
We propose that greater understanding of the inflammatory and bone marrow responses that drive
osteoclastogenesis, and of feedback mechanisms that suppress the adaptive immune response to PJI, will
provide knowledge that can be used to develop new approaches to suppress pathologic bone resorption
and to develop adjuvant immunotherapies to help clear this devastating condition.

Public health relevance
Inflammation and infection induce cells called osteoclasts that cause pathologic bone loss. The goals of this project are to understand mechanisms that induce excessive bone loss and promote persistence of Staphyloccocus aureus periprosthetic joint infection (PJI). We anticipate that our studies will provide knowledge that can be used to develop new therapies to suppress bone resorption and to develop adjuvant immunotherapies to help clear PJI.